P-30 Core Grant for Vision Research Admin Core

ADMINISTRATIVE CORE ABSTRACT/SUMMARY
The Administrative Core coordinates the use of Core resources by members of the
Atlanta Vision Research Community (AVRC). The Administrative Core is managed by
the Program Director (PD), the co-director, an administrative assistant, and the AVRC
Core Advisory Board. The Administrative Core leadership is responsive to the needs of
the end-users, the NEI-R01 grant holders, in the context of and as governed by the best
interests of innovative vision science in the AVRC and the overall missions of the NEI.
The Administrative Core monitors and evaluates the performance of each resource /
service Core, monitors the equitable use of the Cores, resolves conflicts over the use of
Core resources, assists with the purchasing of Core supplies, manages the finances of
the Cores, assists with NIH Public Access Compliance and institutional regulatory
compliance, and performs many other tasks as outlined in the Specific Aims:
Aim 1. To assist with development and support of ARVC members’ research.
Aim 2. To provide financial oversight and assistance to Core investigators.
Aim 3. To effectively administer the operations of the Core.

Public health relevance
Narrative sections are not allowed for the Admin, and Cores A, B, and C modules according to PA-20-051.